GENETICS ®ULATION OF HEME BIOSYNTHESIS IN E COLI

Dr. Cosloy continues to study the genetics and regulation of the heme biosynthetic pathway of Escherichia coli in collaboration with Dr. Charlotte Russell of Area L The heme IX synthesis pathway in E coli has several branches. G1utamyl-tRNA participates in protein synthesis as well as in the synthesis of aminolevulinic acid (ALA), the first committed intermediate in heme biosynthesis. Another branch point occurs at the uroporphyrinogen III step and it leads to sirohydrochlorin or to heme. Sirohydrochlorin is the precursor for the branches leading to Vitamin B12 and to siroheme. Siroheme is a cofactor in the synthesis of cysteine. Heme plays a role in both aerobic and anaerobic respiration, and it has been found that 02 may regulate the production of ALA. These considerations suggest that the control of this pathway requires interesting strategies which are worth investigating.